Investigating gastric inflammation and preneoplastic progression driven by Helicobacter pylori infection

Project Summary
Many cancers are attributed to chronic inflammation, which can cause mutations and activate oncogenic signaling
pathways. An important example is gastric cancer, the fourth-leading cause of cancer death worldwide. At least 80%
of gastric cancer cases are attributed to stomach infection with the bacterium Helicobacter pylori (Hp), which causes
lifelong chronic inflammation that does not eradicate the infection. In some individuals, this inflammation can cause
gastric atrophy, metaplasia (conversion of one normal cell type to another), dysplasia (presence of abnormal
cells) and finally cancer, but the specific mechanism(s) through which Hp triggers this cascade are not well
understood. Similar preneoplastic changes are recapitulated in a mouse model through tamoxifen-induced
expression of active KRAS in the chief cells of the stomach (KRAS+ mice). I found that Hp infection of KRAS+ mice
exacerbated disease: compared to Hp-KRAS+ mice, Hp+KRAS+ mice had an altered trajectory of metaplasia and
accelerated dysplasia. Hp+KRAS+ mice also had expansion of “variant” pit cells (surface mucous cells) that
expressed metaplasia- and cancer-related genes like the mucin Muc4. In accordance with the hypothesis that Hp
causes cancer through eliciting chronic inflammation, Hp+KRAS+ mice had severe inflammation marked by a ten-
fold increase in T cells vs. Hp-KRAS+ mice. In this proposal I will investigate the mechanism(s) through which Hp
worsens disease in KRAS+ mice, with a broader goal of better understanding how Hp infection and its associated
chronic inflammation cause cancer. I hypothesize that Hp modulates the inflammatory response to prevent Hp
eradication from the stomach, and this deleterious immune response leads to metaplasia and dysplasia. In Aim 1 I
will perform targeted depletion of CD4+ and CD8α+ T cell subsets to assess whether immune perturbation impacts
metaplasia, dysplasia and Hp colonization. I will also assess whether T cells traffic to the stomach in Hp+KRAS+
mice or proliferate locally. Finally, I will test whether Hp+ human samples have increased T cells relative to Hp-
samples. In Aim 2 I will investigate candidate Hp virulence factors that modulate inflammation: the cag type IV
secretion system and two proteins that modulate T cells, the toxin VacA and the transpeptidase gGT. I will determine
whether virulence factor mutants can elicit the same inflammatory and disease progression phenotypes in KRAS+
mice as wild-type Hp does. In Aim 3 I will test whether variant pit cells arise from gastric progenitor cells, and will
assess disease phenotypes in Hp+KRAS+MUC4- mice to determine whether Muc4 expression drives pit cell
transformation. I will also perform spatial single-cell RNA sequencing in +/- Hp, +/- KRAS mice to discover whether
variant pit cells share a gene expression signature with Muc4-expressing cells in the “first gland” of the stomach, a
morphologically distinct gland that is believed to be a source of reparative cell lineages. Taken together, the results
of these studies will provide new understanding of how Hp infection and inflammation cause gastric preneoplastic
progression and may reveal new targets for gastric immunotherapy. These findings may also be applicable to other
cancers associated with bacterial infection and/or inflammation, like colorectal cancer.

Public health relevance
Project Narrative Gastric (stomach) cancer is one of the top five causes of cancer and cancer deaths worldwide, and about 80% of cases are due to stomach infection with the bacterium Helicobacter pylori. This project will use new mouse models, human samples, and cutting-edge immune profiling and single-cell sequencing techniques to investigate the mechanism(s) through which chronic Helicobacter pylori infection and associated inflammation promote pre- cancerous changes in the stomach. This research will lead to a better understanding of how inflammation causes cancer and may reveal new immunotherapy strategies for infection-associated cancers.